Cis-Regulatory Circuits for ILC Function and Plasticity

PROJECT SUMMARY
A delicate regulatory balance must be achieved in cells of the innate and adaptive immune systems to
effectively eliminate pathogens, while minimizing damage in neighboring tissues. Defects in regulatory
mechanisms that govern expression of cellular or soluble mediators can interfere with pathogen clearance or
lead to unchecked inflammatory responses associated with autoimmunity. We now appreciate that the innate
immune system includes functional counterparts of T helper (Th) cells, but the innate cells lack antigen-specific
receptors and respond with enhanced kinetics and vigor to danger signals induced by pathogenic insults. The
Th counterparts, called innate lymphoid cells (ILCs), also have been implicated in the pathogenesis of several
autoimmune diseases, including inflammatory bowel disease (IBD). In discovery-driven profiling studies, the
MPIs have defined chromatin landscapes of Th-ILC counterparts derived from human mucosae, revealing
collections of regulatory elements (REs) that may control the expression of key immune mediators. Moreover,
many REs that were active in specific ILC or Th subsets co-localized with disease-associated SNPs, and are
conserved in mice, suggesting they may be important for controlling expression levels of nearby genes in
inflammation-driven pathogenesis. Indeed, the MPIs have defined novel functions for two such REs in
controlling expression of a signature cytokine (IL-22) and a gene required for effector functions in most
lymphoid cells (Tcf7). Despite this progress, the roles of potentially important REs in cell type-, agonist-, and
disease-specific gene expression largely remain untested. The goal of the current project is to address these
outstanding issues, focusing on regulation of a broad panel of signature genes that control ILC-Th function. To
achieve these goals, we will leverage the MPIs’ complementary expertise. Dr. Colonna’s lab discovered
several ILC subsets and continues to contribute to our understanding of their biology in mice and humans. Dr.
Oltz’s lab studies cis-regulatory circuits that drive lymphocyte development and transformation. Two specific
aims are proposed to test the hypotheses that: (i) unique sets of REs are critical for cell type- and agonist-
specific expression of ILC3-Th17/22 cell signature genes in health and disease, (ii) the transcription factors
ZFP683 and PRDM1 orchestrate key aspects of regulomes that govern the biology of natural killer (NK) cells
and their ILC1 counterparts. Continuation of our productive collaboration will identify and functionally test
critical players – both REs and transcription factors – that dominantly regulate expression patterns of genes
involved in inflammatory diseases, providing insights into independent roles of cytokine expressing cells in
pathogenesis, and ultimately opening new therapeutic avenues.

Public health relevance
PROJECT NARRATIVE The immune system strikes a delicate balance between pathogen elimination and protection of host tissue from damage incurred by inflammation during an immune response. Maintaining this balance requires rapid communication between cells of the innate and adaptive immune system and, when disrupted, can produce widespread damage that characterizes many autoimmune conditions. The proposed study will define the regulatory logic driving expression programs for key genes that help establish this cost–benefit balance in specific subsets of innate and adaptive lymphoid cells implicated in inflammatory diseases.